KATP: DYNAMICS OF A CHANNEL-ENZYME COMPLEX

PROJECT SUMMARY
ATP-sensitive K+ channels (KATP) couple a cell’s metabolic state to its electrical excitability. This
process is crucial in pancreatic β-cells where KATP couples glucose uptake to insulin secretion.
In the heart, KATP plays a protective role, opening during hypoxia. The role of these channels is
so vital that KATP dysfunction is associated with diseases of insulin secretion, with severe
mutations causing treatment-resistant syndromes with accompanying neurological deficits. To
study this critical channel, we developed spectroscopic tools that allow us to simultaneously
probe KATP structure and function. This is an ideal approach for understanding KATP’s
physiological role and probing long-standing questions of biochemistry. How is the input of
energy from ligand binding coupled to changes in protein function? How can one
mechanistically separate ligand binding from protein activation? How is long-range
communication achieved between subunits in a multi-protein complex?
KATP comprises four pore-forming inward-rectifier K+ channel subunits (Kir), each associated
with a sulfonylurea receptor (SUR). The connection between KATP and metabolism is
established by ATP/ADP binding to three classes of nucleotide binding site (NBS). Binding to Kir
shuts KATP; binding to two sites on SUR opens KATP. Thus, channel activity is a function of the
occupancy of each NBS and their relative energetic contribution to gating. We have taken a
novel approach to understanding the role of each NBS in KATP gating: measuring site-specific
binding using Förster Resonance Energy Transfer (FRET) between fluorescent ATP derivatives
and channels tagged with fluorescent, non-canonical amino acids. Simultaneous recordings of
binding and ionic current allow us to model each NBS in terms of its nucleotide affinity and
energetic influence on gating. This experimental/analytical framework will be applied to examine
the difference between heart and pancreatic KATP subtypes and the consequences of KATP
mutations associated with diabetes. We will assess the enzymatic activity of SUR (an ATPase)
with mutations in putative catalytic amino acids and novel fluorescent non-hydrolyzable ATP
derivatives synthesized in house. Finally, we will probe the structural basis of coupling between
the Kir and SUR subunits using an enhanced FRET technique in which colored metal ions are
used as short-distance fluorescence quenchers. These combined approaches will yield a new
appreciation for the physiological role of KATP and its dysfunction in certain forms of diabetes.
Novel insights into the energetics and conformational dynamics of KATP will provide a template
for understanding the behavior of other protein complexes.

Public health relevance
PROJECT NARRATIVE ATP sensitive potassium channels (KATP) couple metabolic changes to changes in a cell’s electrical excitability, providing a crucial trigger for insulin secretion in response to elevated blood glucose and a protective response to ischemia in the heart. We have developed a combined spectroscopic and electrophysiological approach to study changes in the structure and function of KATP in response to metabolism. Understanding this process will illuminate KATP’s physiological role, provide mechanistic insight into diseases of KATP dysfunction (like neonatal diabetes), and serve as a template for understanding the structure/activity relationships of other protein complexes.